CHEMOTHERAPY FOR AIDS RELATED NON HODGKIN'S LYMPOMA

This protocol proposes to study and compare the efficacy and toxicity of two treatments. Low dose versus standard dose chemotherapy for patients with non-Hodgkin's lymphoma (NHL) associated with the acquired immunodeficiency syndrome comparison. This is a multicenter Phase III study by the AIDS clinical trial group(actg).